Confirming the use of aberrant T cells as an amyloid-independent blood biomarker for potentially earlier diagnosis and tracking the progression of Alzheimer's Disease

PROJECT SUMMARY
Despite enormous investment into Alzheimer’s disease (AD), all but a few AD drug trials have failed. Major
reasons for these failures have been that AD diagnosis is uncertain in living patients, and is itself based on a
combination of molecular biomarkers and clinical features that occur relatively late in the disease process.
Molecular biomarkers such as imaging or cerebrospinal fluid (CSF) beta-amyloid (Aβ) and/or
hyperphosphorylated tau (pTau), among others, help in more accurately identifying AD patients, but testing for
them is technically demanding, often unavailable, and detects pathologies that can occur irrespective of AD.
Promising blood-based biomarkers are in development but are at best equivalent to CSF markers, and hold
similar challenges. Prominently missing from the AD biomarker portfolio are features upstream of AD molecular
features, which, by their closer proximity to disease initiation, have greater potential for earlier detection and
tracking of AD. A simple blood-based biomarker detectable prior to Aβ or pTau abnormalities would thus be a
breakthrough in Alzheimer’s diagnostics and drug development. Alterations in age-related cytolytic (CD8) T cells
could in theory impact AD pathology upstream of Aβ and pTau. We have shown in mice that certain age-related,
self-peptide (Amyloid Precursor Protein; APP)-specific CD8 T cells enter the brain, initiating the accumulation of
Aβ plaques, Tau+ neurofibrillary inclusions, neuroinflammation, and ultimately, profound neurodegeneration and
cognitive decline resembling sporadic AD in humans. Findings from this model allowed successful prediction of
previously unknown features of human AD. In this context, levels of age-related T cells responsive to a nearly
identical APP antigen as in mice corresponded to sporadic AD and AD-related Mild Cognitive Impairment (MCI)
in human patients, with potentially greater specificity than an emerging plasma biomarker, P-Tau217. T-Neuro
has exclusively licensed this technology, with the ultimate goal of producing a T cell-based blood biomarker kit
(“T-Track”) to help diagnose AD for clinical trial recruitment and primary care testing. Necessary steps to more
extensively validating T-Track for such uses include initial confirmation in large, well-defined patient cohorts, as
well as expansion to patients not currently suitable for the test (HLA-A2-negative). In Aim 1, we will determine
the feasibility of the T-Track biomarker to sensitively and specifically track AD status in HLA-A2-positive
individuals, providing necessary proof-of-concept for the T-Track assay. In Aim 2, we will expand application of
the T-Track biomarker assay to HLA-A2-negative subjects, by quantifying antigen- and HLA-independent
markers of age-related T cells, as well those specific for related antigenic (APP) peptides+other HLA subtypes.
Upon completion of the Phase I study, we will have determined the feasibility of quantifying HLA-A2/APP-reactive
CD8 T cells in blood to identify AD and progression to AD in patients and expanded the T-Track biomarker assay
to other HLA subtypes. This is an initial step in more extensive T-Track validation in Phase II and will substantially
de-risk its continued development into a diagnostic kit in Phase III for earliest detection and prediction of AD.

Public health relevance
PROJECT NARRATIVE The successful development of an early, blood-based Alzheimer’s diagnostic, such as T-Track, would have significant impacts on human health. First, individuals could receive earlier and more accurate diagnoses, leading to better disease management and improved quality of life. Second, it could facilitate the earlier enrollment and ongoing disease monitoring of patients in Alzheimer's clinical trials, which would increase the efficiency and cost-effectiveness of clinical trials. Finally, it could reduce the burden on healthcare systems and caregivers, as early diagnosis and treatment may delay the need for costly and intensive care.